Genome editor therapy for Angelman syndrome

PROJECT SUMMARY
Angelman syndrome (AS) is a severe neurodevelopmental disorder that is caused by deletion or mutation of the
maternally inherited UBE3A allele. The paternal UBE3A allele is silenced in cis by a long non-coding antisense
RNA (UBE3A-ATS) exclusively in neurons. This biology explains why deletion of maternal UBE3A results in
near-complete loss of UBE3A protein in the nervous system. We recently found that an adeno-associated virus
(AAV)-Cas9 vector can be used to unsilence paternal UBE3A (patUBE3A) in mouse and human neurons when
targeted to UBE3A-ATS. However, as a potential safety concern, the AAV vector integrated into Cas9-generated
double-strand breaks at guide RNA target sites. In preliminary studies, we found that a Cas9 nickase (nCas9)
AAV vector did not integrate at target sites and was more effective at unsilencing patUbe3a when compared to
an equivalent Cas9 cleavase vector. Preclinical studies suggest that AS could be prevented or reduced in
severity if patUBE3A is unsilenced in the early postnatal period. Thus, the overarching goal of this project is to
de-risk the neonatal use of an AAV-nCas9 genome editor vector to enduringly treat AS. We will advance this
somatic genome editor therapy as follows, Discovery (UG3) phase (2 years): 1) We generated a knock-in mouse
harboring ~170 kb of human UBE3A-ATS sequence and validated its utility with antisense oligonucleotides and
with AAV-Cas9 vectors that target human UBE3A-ATS. We will identify lead AAV-nCas9 vectors that target
human UBE3A-ATS and perform biodistribution studies with this innovative humanized mouse line. 2) We will
independently validate on-target activity of the lead vectors and evaluate potential off-target activities with human
neurons containing the maternal 15q11-q13 deletion that typically causes AS. One lead vector will be selected
as the clinical candidate using quantitative selection criteria and advanced to the Development (UH3) phase (3
years): 3) Complete development phase preparatory activities, including large-scale manufacturing of the clinical
candidate vector with a NIH Blueprint Neurotherapeutics Network contractor and initiate the pre-investigational
new drug (IND) meeting with the Food and Drug Administration (FDA). 4) Perform IND-enabling studies in
rodents and rhesus monkeys. We will de-risk early postnatal use of the clinical candidate vector in rhesus
monkeys, a species that closely models human neurodevelopment. All assays are in-place to quantify target
engagement, biodistribution, and vector safety. Short and long-term IND-enabling safety studies are proposed,
including noninvasive, longitudinal in vivo imaging in rhesus monkeys to assess the potential for adverse findings
such as neuroinflammation. An IND application will be prepared and submitted to the FDA at the conclusion of
the proposed studies.

Public health relevance
PROJECT NARRATIVE The family burden and health care costs associated with Angelman syndrome (AS) are immense, as affected individuals require support and care across a full lifespan. Postnatal administration of a genome editor to restore UBE3A levels in the brain soon after birth could prevent or greatly reduce symptoms associated with AS. The proposed studies will advance the first “one-and-done” genome editor-based treatment for an autism spectrum disorder and could enable future use of similar genome editors in the early postnatal period to treat other highly penetrant neurogenetic disorders.